Lamin B2 regulates nuclear remodeling in cardiomyocyte terminal differentiation

ABSTRACT
Heart disease is the leading cause of morbidity and mortality worldwide. Different types of heart injury lead to
the development of heart failure, a chronically progressive disease. Heart failure is characterized by increased
cardiomyocyte death and insufficient regeneration of new ones. As such, increasing cardiomyocyte
regeneration and decreasing death represent targets for new therapies. This application is for developing a
transformative paradigm connecting these important cellular mechanisms with nuclear remodeling in
cardiomyocyte differentiation.
Our new results show that when cardiomyocytes differentiate they decrease the number of nuclear
pores (NP). NP are large channels of > 100 nm outer diameter for communication between the nucleus and
the cytoplasm. NP, along with the nuclear lamina (NL), function in regulating the nuclear transport of signaling
molecules and chromatin organization. Although heart failure alters nuclear transport, the structural and
functional changes of NL and NP changes during terminal differentiation are unknown. To determine the
molecular mechanisms directing the decrease of NP, we have used single-cell transcriptional profiling, which
identified a decrease in expression of lamin B2 (Lmnb2), an intermediate filament and component of the NL,
during cardiomyocyte differentiation. Our new results show that Lmnb2 gene knockout in cardiomyocytes
blocks M-phase, that is, nuclei do not divide, and instead become polyploid. In addition, the M-phase block
decreases NP incorporation. As a result, although the DNA contents of nuclei (ploidy) increases, the number of
NP decreases by 50%. The lower NP number identifies a central event in nuclear remodeling, as it indicates
not only altered nuclear transport, but also altered chromatin structure. Together, this could explain the
decreased ability of terminally differentiated cardiomyocytes to activate cell cycle genes and their increased
susceptibility to cell death.
This proposal aims to develop a new mechanistic paradigm of nuclear remodeling in cardiomyocyte
differentiation, which is synergistic with recent advances in characterizing chromatin changes. We will test the
central hypothesis that decreased Lmnb2 gene expression is a central mechanism of nuclear
remodeling in cardiomyocyte differentiation. We have assembled an interdisciplinary research team and
prepared innovative techniques (super-resolution microscopy, single-cell RNAseq, ATACseq) that, combined
with cardiomyocyte-specific Lmnb2flox inactivation and viral expression of Lmnb2, will enable us to determine its
role in nuclear remodeling in cardiomyocyte differentiation.
The anticipated results will enable future research toward understanding and targeting nuclear
remodeling in myocardial development, regeneration, and disease. This will be broadly significant for patients
with congenital and acquired heart diseases.

Public health relevance
NARRATIVE Heart failure is a significant health problem. The proposed research could develop a new paradigm of remodeling of the nucleus in heart muscle cell terminal differentiation, which could explain the decreased regenerative capacity in adult mammalian hearts.